Language Control across Comprehension and Production in Unimodal and Bimodal Bilinguals

Unimodal and bimodal bilinguals’ language control mechanisms differ in many ways in both comprehension
and production. Unimodal bilinguals process two languages through the same perceptual and motoric systems,
whereas bimodal bilinguals engage separate systems for each language. However, little is known about how
each group manages language control when comprehension and production intersect, a frequent occurrence
in everyday communication such as dialogues. This question is critical, as language control mechanisms in
comprehension and production are largely separated. Do bilinguals oscillate between different control
mechanisms in daily communication, or do they adaptively adopt a more integrated approach for efficiency? Is
it affected by language modalities or experiences? Addressing these issues, the long-term goal of this proposal
is to develop a comprehensive understanding of language control across comprehension and production in
diverse bilinguals, thus facilitating the development of tailored diagnostic tools, interventions, educational and
communication strategies for diverse bilingual children and adults. The proposed project will lay foundation to
achieve this goal through comparing unimodal and bimodal bilinguals’ performance when they switch
languages from comprehension to production. Through a series of experiments involving alternation between
listening/sign comprehension (judgment of words or sentences) and production (picture naming), we will
explore how unimodal and bimodal bilinguals address language switching and mixing. These experiments will
be conducted in various contexts (e.g., whether production is restricted to one language or can be in both
languages), a manipulation based on the framework of adaptive control. In Aim 1, we will investigate unimodal
and bimodal bilinguals’ reliance on reactive control by examining language switch costs. In Aim 2, we will
investigate their reliance on proactive control by examining language mixing costs and blocked language order
effects. This dual focus is critical to a holistic understanding of language control mechanisms, as reactive and
production control are two separate processes. Previous research has predominantly concentrated on reactive
control, which resolves cross-language interference when it occurs. Proactive control, which operates in
anticipation of interference, is underexplored in the comparison between unimodal and bimodal bilinguals.
Based on our preliminary results, we hypothesize that unimodal and bimodal bilinguals will adopt reactive
control differently across comprehension and production in various contexts but adopt proactive control in a
similar fashion. We will also consider how bilinguals’ degree of bilingualism affects the language control
mechanisms. The findings of this project will contribute to the development of clinical and educational practices
that accommodate the nuanced needs of bilingual individuals, such as tailored communication strategies with
unimodal bilingual children and CODAs (Child of Deaf Adults), supporting a broader goal to understanding and
facilitating human development in its diversity.

Public health relevance
Unimodal and bimodal bilinguals employ different language control mechanisms for comprehension and production, but how they manage two languages when these two processes intersect—common in everyday communication—remains unclear. This proposal seeks to address this gap by examining how unimodal and bimodal bilinguals adopt reactive and proactive control across comprehension and production in various linguistic contexts, considering their individual language backgrounds. By offering novel insights into adaptive language control, this research will lay the foundation for developing theory-driven diagnostic tools, interventions, educational and communication strategies to better support diverse bilingual children and adults in clinical and educational settings.